Pilot Grant Program

PROJECT SUMMARY - PILOT GRANT PROGRAM (PGP)
The Pilot Grant Program of the Environmental Health Sciences Research Center (EHSRC) is a critical and
valuable component of the EHSRC, serving the research, career development, and training missions of the
Center. The Program advances the careers of talented new investigators by bringing them into environmental
health science research and offers a way for more senior researchers to nurture innovative new ideas. The
Specific Aims of the EHSRC PGP are to: Aim 1) provide initial support for new investigators (early in the
development of their independent research career) to establish new lines of environmental health research; Aim
2) provide services of state-of-the-art Facility Cores to pilot grant investigators to enhance their research and
reduce their costs; Aim 3) facilitate exploration of innovative new directions in environmental health for
established investigators; Aim 4) stimulate investigators from other disciplines to apply their expertise to
environmental health research; and Aim 5) foster new interdisciplinary collaborations through awarding of pilot
projects to investigators who have not previously worked together. The PGP encourages University of Iowa
researchers to apply for a pilot grant in an R21-style proposal. Pilot grant applications are reviewed by the internal
advisory board, subject-area experts as needed, and Associate Members as part of the Career Development
Program in a process tailored after federal study sections.